Improving Perception in Digital Breast Tomography

Digital Breast Tomosynthesis (DBT) is a breast cancer screening methodology in which radiologists
search for cancer in 3D volumes of virtual slices through the breast. DBT performs better than classic,
2D mammography but it takes more time. Our goal is to compare different methods that could reduce
the time required while maintaining or improving performance. Beyond the specific goal of improving
DBT, we will uncover general principles of attention and perception that can be applied whenever the
volume of images threatens to overwhelm the ability of observers to consume those images. We are
particularly interested in conditions of “low target prevalence” (low percentage of positive cases). In
tasks like breast cancer screening, with many images and very few clinically significant targets,
interventions that are effective when tested at high prevalence in the lab may fail in the field when
prevalence is much lower. There are three projects:
Project 1: Self-Triage by 2D Full-field digital mammography or synthetic images: In screening for
breast cancer, there will be some cases that a reader could safely declare ‘normal’ on the basis of the
2D image, alone. Is it reasonable to develop a protocol where some DBT images would be acquired
but would not be examined? This “self-triage” would require a very conservative triage criterion in order
to avoid triage of any positive cases, but if proven to be safe, self-triage could save significant time and
might reduce false negative errors.
Project 2: DBT as “hybrid search”: Breast cancer screening involves search for more than one type
of target (masses and calcifications, at minimum). Research shows instances where such ‘hybrid’
search for multiple targets leads to elevated errors. We will test the hypothesis that readers are more
efficient and/or more accurate if they perform separate searches for each target type. We will measure
eye movements to compare search for each target type alone to search for both types together.
Experiments with non-experts will investigate basic principles of search in 3D volumes of image data.
Project 3: AI Targeted ‘drilling’: Eye tracking has identified two modes of search in 3D stacks of
images: “drilling”, where readers move rapidly through depth (Z) while the eyes stay relatively stable in
the XY plane, and “scanning”, where readers search widely in XY while moving slowly in Z. We will use
eye tracking to evaluate a CAD system developed by iCAD that marks specific locations in the 2D XY
image and invites readers to drill in these specific areas. Does that improve CAD performance?
Summary: This program of research will produce recommendations for increasing the efficiency of
breast cancer screening. Moreover, each study will produce basic science that will be generalizable to
other settings and will deepen our understanding of visual search through 3D volumes of image data.

Public health relevance
8. PROJECT NARRATIVE Digital breast tomosynthesis (DBT) is a technology that improves breast cancer screening accuracy over classic mammography but its large number of images means that it takes more time to read. We will investigate a series of interventions that can improve the speed and/or accuracy of DBT cancer screening. What we learn will advance our fundamental understandingof visual search and will be useful in any setting where technology has produced more images than users have time to examine.